Bioinformatics/ Biostatics Core

The Bioinformatics/Biostatistics Core (BBC Core) will set up a Laboratory Information Management System (LIMS) using the open source Sesame software and establish a project data integration web site (e.g.,http://toro.aecom.yu.edu/biodefense/). All primary and processed data will be placed on the web site. Patient data will be kept by MIS at Montefiore Medical Center. A firewall has been established so that patient data cannot be accessed. Only patient and sample codes for proteomics will be provided for the analysts. The Bioinformatics/Biostatistics Core will also provide consulting on advanced study design, sample size justification and statistical analysis of quantitative expression with parameters reflecting the individual projects, and decode the samples to correlate with appropriate parameters, such as [unreadable] HIV, [unreadable]HAART, [unreadable] IPS,[unreadable] buprenorphine, cytokine expression, neurological symptoms, transmigration rates, etc.